Impact of Nicotine Messaging on Nicotine Beliefs and Tobacco Use Behavior

PROJECT ABSTRACT
FDA’s comprehensive plan on tobacco and nicotine regulation focuses on two key actions: 1) reducing
nicotine levels in combustible cigarettes to make them minimally or non-addictive and 2) allowing for new forms
of nicotine delivery to provide adult smokers with nicotine with lower resulting health harms than cigarettes. The
public health impact of FDA’s proposed nicotine reduction policy hinge on the extent to which tobacco users and
non-users understand the harms of nicotine in relation to specific products (e.g., e-cigarettes, nicotine
replacement therapy (NRT), reduced nicotine content (RNC) cigarettes) and how this influences decisions made
by non-users to try a product and by users regarding cessation, product switching, or continued use. Population
data, including recent work by our group, highlight widespread public misperceptions of the health risks of nicotine
that could undermine the public health benefits of FDA’s comprehensive plan. As a result, the introduction of FDA
policies that reduce nicotine in some tobacco products while leaving it unregulated in others may require more
nuanced public education about nicotine. Findings from our pilot work support that a brief nicotine corrective
messaging intervention—similar to the messages likely to be seen on warning labels or in public education media
campaigns—can correct misperceptions of nicotine, NRT, e-cigarettes, and RNC cigarettes in an online
convenience sample of U.S. adults. The proposed study extends our pilot work to examine the effect of multiple
exposures to nicotine corrective messaging (NCM) intervention (compared to a delayed intervention control) on
nicotine beliefs and intention/use of tobacco and nicotine products in two parallel and complementary samples.
A population-based study will estimate the potential public health impact of NCM on nicotine beliefs and tobacco-
related behavioral intentions in 715 adult tobacco users and non-users, including potential unintended effects. A
lab-based study will estimate the independent effects of NCM and RNC cigarettes, as well as their interaction,
on nicotine beliefs and observed tobacco use behavior in 160 adult smokers who are explicitly told whether they
have a normal nicotine content or RNC cigarette (i.e., unblinded). This study aims to provide insight into the real
world impact of NCM communication efforts on tobacco use behavior in the general population and in adult
smokers affected by a reduced nicotine content standard in combustible cigarettes. This study will test a set of
evidence-based messages on nicotine, providing information on content and themes that could be used in future
public education on nicotine to maximize the public health benefit of FDA’s comprehensive plan.

Public health relevance
PROJECT NARRATIVE The current study tests the impact of multiple exposures to a brief nicotine corrective messaging intervention on beliefs about nicotine and on intention and use of tobacco and nicotine products in two parallel and complementary studies: a population-based study of adult smokers and non-smokers followed for 12 weeks and a lab-based study of adult smokers followed for 4 weeks who also receive normal nicotine content or reduced nicotine content cigarettes and are explicitly told which product they have been given (i.e., unblinded). It fills a notable gap in research to guide public education on nicotine, as well as estimating the likely impact of a nicotine product standard on beliefs and behavior, both essential to conducting regulatory impact analyses and supporting FDA’s comprehensive plan on tobacco and nicotine regulation.